RAMAN SPECTROSCOPIC INVESTIGATION OF LENS AGING &CATARACT FORMATION

We have characterized the gamma crystallin proteins and also chemically modified gamma crystallin proteins using 647 nm excited Raman spectroscopy. The control proteins and aging induced proteins show distinct spectral features. For example, in the case of the control crystallin protein, S-H bands near 2700 cm-1 are intense. As the protein ages (induced by chemical agents) for a few weeks the the S-H band decreases with concomitant increase in S-S stretch near 512 cm-1. PH induced oxidation-reduction in these proteins have also been studied spectroscopically to verify this hypothesis. In the next step, the ability of Raman spectroscopy to quantitate these age induced oxidation-reduction reaction in gamma crystallin will be studied and compared with other standard invasive procedures.